Unraveling Proteasome Inhibitor-Induced Cardiovascular Toxicity through Integrative Multiomics

PROJECT SUMMARY
Proteasome inhibitors (PIs) represent novel cancer therapeutics highly effective in treating hematologic
malignancies and have remarkably improved cancer survival rates. However, the utilization of PIs, particularly
carfilzomib (CFZ), is largely hampered by substantial cardiovascular toxicity, which occurs through poorly
characterized mechanisms. In this proposal, we aim to leverage a humanized multiple myeloma (MM) mouse
model, human induced pluripotent stem cells (iPSCs), CRISPR interference and activation (CRISPRi/a) screens,
single-cell RNA sequencing (scRNA-seq), deep learning, and RNA splicing biology to elucidate the molecular
signatures underlying CFZ-induced cardiovascular dysfunction. We will focus on investigating the role of
pathogenic alternative splicing events (ASEs) in smooth muscle cells (SMCs) and endothelial cells (ECs) in both
mice and iPSCs. Finally, we will employ antisense oligonucleotides (ASOs) targeting candidate pathogenic ASEs
to evaluate their effectiveness in preventing or mitigating CFZ-induced cardiovascular toxicity. In Aim 1, we will
confirm CFZ-induced cardiovascular dysfunction phenotypes (e.g., hypertension, microcirculation dysfunction,
and cardiac hypertrophy) in an MM mouse model and collect vehicle- and CFZ-treated mouse aortas for scRNA-
seq. We will then perform extensive alternative splicing analysis using two novel algorithms, SpliZ and SpliceAI,
developed by our team. In Aim 2, we will differentiate pooled iPSC lines derived from healthy donors and CFZ-
treated cancer patients with or without cardiovascular phenotypes (5M+5F/group) into iPSC-SMCs and iPSC-
ECs and construct 3D-engineered vascular tissues (iPSC-EVTs). We will select species-conserved, CFZ-
induced differentially expressed splicing factors predicted to be pathogenic to conduct CRISPRi/a screens in
pooled iPSC-EVTs and identify causal genes downstream of candidate splicing factors. In Aim 3, we will employ
minigene splicing assays to confirm putative pathogenic ASEs in identified causal genes and design specific
ASOs to block their activity. Therapeutic efficacy of ASOs will be validated first in primary and iPSC-derived
EVTs. Promising candidate ASOs will undergo further validation in MM mice to evaluate their rescue effects on
CFZ-induced hypertension, thrombosis, arrhythmia, and cardiac dysfunction. We anticipate that the successful
completion of these studies will provide new mechanistic insights into CFZ-induced cardiovascular dysfunction
and facilitate the development of novel therapeutics, enabling cancer patients to safely receive life-saving PI-
based therapies. Moreover, this proposal will contribute novel insights into the role of aberrant alternative splicing
in vascular pathology beyond the scope of cardio-oncology.

Public health relevance
PROJECT NARRATIVE Carfilzomib (CFZ), a second-generation proteasome inhibitor, demonstrates high efficacy against hematologic malignancies, but its clinical use is hindered by significant cardiovascular adverse events, including hypertension, arrhythmia, thrombosis, and heart failure. This proposal aims to elucidate the mechanisms of CFZ-induced vascular dysfunction by utilizing advanced techniques, including iPSC technologies, tissue engineering, single- cell RNA sequencing, deep learning, CRISPR perturbation screens, RNA alternative splicing biology, and antisense oligonucleotide-based gene therapy. The findings from this study will offer novel insights into the pathogenic alternative splicing isoforms in CFZ-induced cardiovascular toxicity, which will facilitate the development of molecularly targeted therapeutics tailored to specific cardiovascular cell types.